Technologies for OUD Prevention, Control and Supportive Care - Development of Patient/Caregiver mobile application and Provider Dashboard

ABSTRACT
Pain is an important issue for both society and health care. The increasing frequency of individuals with chronic
pain as the result of chronic diseases and postoperative pain have directly led, over the past two decades, to the
over-prescription and misuse of opioids. In early 2019, an estimated 130 people per day were dying from opioid-
related drug overdoses, 2 million people were misusing first-time opioid prescriptions, and almost 33000 deaths
were attributed to overdosing with synthetic non-methadone opioids in the USA alone. Even though respiratory
depression and complete respiratory arrest are the major causes of mortality with opioid overdose, there is
currently a serious knowledge gap in our understanding of the underlying mechanisms of opioid pain relief and
respiratory depression by opioids, and how these mechanisms differ from each other. Aidar Health’s ground-
breaking technology offers a rapid medical assessment device, MouthLab, which non-invasively measures 10+
vital medical parameters in under 60 seconds, and an enterprise platform that leverages data science, to create
a new kind of precision medicine through clinical-grade monitoring, at home. A point-of-care solution such as
MouthLab is fundamental in understanding the impact of prescribed opioids and synthetic drugs, its impact on
the underlying chronic condition and effectiveness of mitigation strategies. Powered by AI and machine learning,
Aidar’s proprietary software would be able to provide deeper, real-time insights of subtle changes in physiology
to assist the provider with decisions related to drug titration, treatment changes, adjunct therapies before any
adverse event can occur. MouthLab’s ability to combine a wide-ranging spectrum of cardiopulmonary
measurements (i.e. SpO2, Heart rate, Heart rate variability, Respiratory Rate, Respiratory Flow Cycle
Morphology, Spirometry), would be able to solve the problem of lack of real-time health insights which would
have significant relevance to providers in the treatment development process through the collection of multiple
biomarker data linked to opioid-induced respiratory depression. This product creates a fundamental shift in the
technology employed at home by identifying early warning symptoms through a multiparameter approach and
facilitates understanding of the underlying mechanisms linking pain relief with control of breathing to identify pain
therapies with minimal or no respiratory side effects. The novelty is affirmed with two approved patents and the
freedom to operate analysis that found no prior art of concern. The goal of this project is to develop software
infrastructure that would enhance the progressive and holistic monitoring of users experiencing OUD. By the end
of this award, the company will test and validate the newly developed software capabilities in a small cohort of
patients and controls at TentHouse Health & Wellness. Our solution has a validated business model (through
over 100 consumers at Johns Hopkins Hospital and with 6 Pharmaceutical customer interviews) that drive value
for patients, physicians, biopharmaceuticals, and payers. A successful development of this product is forecast
to create 43 new jobs (2022) with an annual payroll exceeding $11.5M. As a direct result of this award, this
innovative product can reach the U.S. market in 2022, with $123M in projected revenue by 2025. Our mission is
to empower the uses and improve the quality of life of every individual with OUD. MouthLab will essentially be
like a ‘Check Engine’ light for individual with OUD.

Public health relevance
NARRATIVE Pain is an important issue for both society and healthcare. In the USA, the annual burden on society has been estimated at $560-$635 billion. The increasing frequency of individuals with chronic pain as the result of chronic diseases and postoperative pain have directly led, over the past two decades, to the over prescription and misuse of opioids. Using Aidar’s rapid health assessment device, MouthLab, we aim to measure 10+ vital health parameters and by developing unique software capabilities we offer providers and caregivers the access to user- level data and key health insights, in real-time, for early detection of health deterioration and timely intervention at home. By removing the barriers to clinical care and research, we are in parallel capturing the largest digital dataset on human health and disease, which will transform our understanding of health, behavior, and OUD-related mitigation strategies.